SECURE PLATFORMS SUPPORT FOR THE NATIONAL CLINICAL COHORT COLLABORATIVE (N3C) DATA ENCLAVE AND NIDAP

Secure Platforms. Support for the National Clinical Cohort Collaborative (N3C) Data Enclave and the NCATS Integrated Data Access Portal (NIDAP) with Palantir Technologies, Inc.
and
Support for the PEPFAR Data Innovation Project, with Palantir Technologies, Inc.,
The NCATS secure scientific platform environment is a specialized cloud-based data aggregation
and analytics enclave sponsored by NCATS that can integrate, manage, secure, and analyze any
kind of scientific data, and provide secure, controlled access to internal and external collaborators.
NCATS’ ongoing research landscape, with research predating January 20, 2025, involves the data
secured in this platform. This research includes everything from the raw and processed data
generated by the NCATS laboratories (such as high-throughput screening data) to extensive
anonymized clinical health observations supporting patient-level medical research.